The role of CIB1 on cutaneous papillomavirus replication and transcription

Project Summary/Abstract
Cutaneous papillomaviruses (PVs) can cause severe, persistent infections and skin cancer in
immunodeficient patients. These patients include those with human immunodeficiency virus, organ transplants, and
primary immunodeficiencies. Prophylactic PV vaccines developed to target mucosal PVs are not effective against
cutaneous PVs, and treatments are limited and often ineffective. Thus, there is a critical need to identify targeted
therapeutics for treatment of cutaneous PV infections and PV-associated skin cancers. Epidermodysplasia
verruciformis (EV), a genodermatosis, offers a unique opportunity to study mechanisms of cell intrinsic host defense
against PV in the skin, as these patients are highly susceptible to cutaneous PV infections but have no increased
susceptibility to other infections. A recent study identified a cohort of EV patients with null mutations within calcium-
and integrin-binding protein-1 (CIB1), as well as decreased CIB1 expression in EV-patients with other, more
common, mutations that affect ~50% of EV patients. Collectively, these findings suggest that CIB1 is a key player in
immunity to cutaneous PV infections and may act as a restriction factor against cutaneous PVs. EV, though, is a
rare disease and thus obtaining clinical specimens for evaluation and future therapeutic testing is problematic. We
have, however, discovered a naturally occurring EV-like disease in dogs which appears to mimic the human
disease in several critical aspects: A) Like humans with EV, affected dogs acquire disseminated cutaneous PV
infections that are refractory to treatment and can progress to cancer; B) Like humans, these dogs have restricted
susceptibility to cutaneous PV infection; and C) Like humans, the disease occurs spontaneously. We propose the
dog as a model for studying PV infections in immunocompromised patients. This could be the most valuable animal
model to date to study not only the underlying pathogenesis of EV, but also identify conserved mechanisms of
intrinsic keratinocyte defense against PV infections. Importantly, preliminary studies from our laboratory have
demonstrated decreased expression of CIB1 in keratinocytes from EV-like dogs, highlighting a conserved
mechanism underlying susceptibility to PV infections between humans and dogs, linked to CIB1. We hypothesize
that impaired CIB1 expression enhances PV replication and transcription in keratinocytes in both humans and dogs
with EV. In Aim 1, we will determine if CIB1 expression in impaired in dogs with EV-like disease, and in humans
and dogs with another form of EV caused by IL2RG mutations. In Aim 2, we will determine if CIB1 expression
regulates PV replication and transcription within keratinocytes, and if this is conserved between the dog and human.
Using human PV and keratinocytes will address the human disease; using canine PV and keratinocytes will
advance the dog model. Results will directly inform the next phase of experiments, and future R01 proposal,
designed to elucidate molecular mechanisms of PV susceptibility in EV patients. With improved understanding
of the molecular pathogenesis of these infections, targeted therapeutics may be further developed, which would
ultimately improve the quality of life for patients with these devastating infections.

Public health relevance
Project Narrative Cutaneous papillomaviruses cause severe and extensive skin infections in immunocompromised people, particularly patients with the genodermatosis epidermodysplasia verruciformis (EV), where loss of calcium- and integrin-binding protein-1 (CIB1) expression within keratinocytes is thought to lead to increased papillomavirus replication. The goal of this research is to determine if there is a conserved mechanism in humans and dogs for enhanced papillomavirus replication and transcription through loss of CIB1 expression. With improved understanding of the molecular pathogenesis of these infections, targeted therapeutics may be further developed, which would ultimately improve the quality of life for patients with these devastating infections.